Point-of-Care Brain Magnetic Resonance Imaging in Children with Head Trauma (BRAINCHILD)

PROJECT SUMMARY/ABSTRACT
Traumatic brain injury (TBI) is a predominant cause of disability and death among children, leading to over
800,000 emergency department (ED) visits and 6,000 deaths annually in the U.S. Over 30% of children
presenting with head trauma are subjected to computed tomography (CT), the standard neuroimaging modality
in acute evaluations, to detect clinically meaningful TBIs. While CT is efficient, it exposes the pediatric brain to
ionizing radiation, thereby increasing potential for future cancer risk. Given the importance of identifying TBI
while also minimizing potential hazards, there is a need for safer and equally effective neuroimaging alternatives.
Magnetic resonance imaging (MRI) offers a radiation-free alternative to CT. Conventional MRI, although superior
in identifying certain intracranial injuries, is not frequently employed in acute TBI scenarios due to constraints
like scanner accessibility. However, recent advances have presented point-of-care, low-field brain MRI (POC
LF-MRI) systems as a potential paradigm-shifting neuroimaging modality. These systems are cost-effective,
portable, user-friendly, and have FDA clearance across all age groups. Notably, they enable bedside
neuroimaging, which is immensely beneficial for critically injured patients who can't be safely moved. This project
endeavors to bridge the existing knowledge gaps regarding the accuracy and feasibility of POC LF-MRI in
emergency and critical care for pediatric head traumas through a prospective, single-center, observational cohort
study of ED, hospitalized, and intensive care unit (ICU) children. Our research aims to (1) determine the accuracy
of POC LF-MRI for TBI compared to current clinical standard of care initial neuroimaging, (2) determine the
accuracy of POC LF-MRI for neuroradiographic injury progression on repeat neuroimaging, and (3) determine
feasibility metrics and balancing measures of POC LF-MRI, including order to scan time, scan duration,
incomplete scan proportion, and ED length-of-stay. In summary, our multidisciplinary team seeks to ascertain
the diagnostic accuracy and operational feasibility of POC LF-MRI, potentially transforming the neuroimaging
approach for pediatric trauma care. If successful, this could reduce radiation exposure risks, augment patient
safety, cut healthcare costs, and broaden neuroimaging access in acute care.

Public health relevance
PROJECT NARRATIVE This project investigates the accuracy and feasibility of using point-of-care, low-field brain magnetic resonance imaging (POC LF-MRI) for diagnosing traumatic brain injury (TBI) in children, a population vulnerable to the harmful ionizing radiation of traditional CT scans. Through a comprehensive, observational cohort study, we aim to compare the accuracy of POC LF-MRI against the current standard of care, assess its capability to track injury progression, and evaluate its practical metrics in emergency and critical care settings. Our goal is to determine if POC LF-MRI can provide accurate, efficient, and more accessible neuroimaging, potentially redefining pediatric trauma care while reducing ionizing radiation risks and enhancing patient safety.